FDA Drug Residue Avoidance Cooperative Agreement

FDA Drug Residue Avoidance Cooperative Agreement Abstract RFA-FD-025 The proposed purpose of this cooperative agreement is to promote the prevention of illegal drug residues in food of animal origin. Our efforts will be targeted in the following areas: • Increase participation in the NYSCHAP Food Safety and Drug Avoidance Module • Create a reference notebook for distribution to producers • Develop a webpage • Continuing education for food animal veterinarians • Educational outreach to violators and their veterinarians

Public health relevance
FDA Drug Residue Avoidance Cooperative Agreement Proposal Narrative RFA-FD-025 The New York State Department of Agriculture and Markets / Division of Animal Industry is proposing to enter into a cooperative agreement with the FDA to enhance our current program promoting the prevention of illegal drug residues in food of animal origin. Our current program is centered on the Food Safety and Drug Residue Avoidance Module, a component of the New York State Cattle Health Assurance Program (NYSCHAP). This effort will include outreach to current NYSCHAP participants to increase participation in the module as well as efforts to expand NYSCHAP participation. Efforts will also be made to expand the distribution of drug residue avoidance information to producers beyond NYSCHAP participants. This will include development of a reference notebook with record keeping forms and guidance useful at the producer level. Mass communication in the form of a webpage and email newsletters will be key components of the project. In addition food animal veterinarians will be targeted for outreach. Producers who have been investigated by FDA for a drug residue will be offered an educational visit. This would be done with the permission of the local FDA office and would be voluntary on the part of the producer. We would also involve the attending veterinarian. The purpose of this outreach is to offer practical guidance and materials to the violative producer to hopefully result in a reduction in repeat violators. Goals Year 1  Develop webpage  Develop content for notebook and produce and distribute 1000 copies  100 NYSCHAP producer contacts  9 CE seminars for veterinarians  30 veterinary practice meetings  20 post investigational educational visits Goals Year 2 and 3  Update webpage as necessary  Update and produce notebooks, 1000 per year  100 NYSCHAP producer contacts  9 CE seminars for veterinarians  20 practice meetings  20 post investigational educational visits